Postsynaptic Signaling by Norepinephrine and cAMP

Postsynaptic Signaling by Norepinephrine and cAMP
Abstract
Norepinephrine (NE) regulates attention and alertness. The β2AR adrenergic receptor (β2AR) is the prevalent
postsynaptic NE effector at glutamatergic synapses, where it interacts with AMPARs and the postsynaptic L-
type Ca2+ channel (LTCC) CaV1.2. These complexes also contain all downstream effectors of β2AR (Gs, adenylyl
cyclases (ACs) and the cAMP-dependent protein kinase PKA) for highly localized signaling by cAMP (see our
pioneering work in Science 293, 98; Science 293, 2205; EMBO J 29, 482; EMBO J 35, 1330; Science
Signaling10, eaaf9659 and eaaf9647). Our exciting preliminary data indicate that 1) NE enters neurons and
endosomes via the NE transporters OCT3 and PMAT to stimulate intracellular β2AR signaling and drive AMPARs
to the cell surface; 2) the cAMP degrading phosphodiesterase PDE4A5, which is increased during sleep
deprivation and mediates the resulting memory impairment, is linked to the β2AR - AMPAR complex via PSD-
95; 3) CaV1.2 forms a supercomplex with AMPARs, which allows efficient activation of CaV1.2 during synaptic
transmission at postsynaptic sites with NE present. Aim 1 is to test whether activation of intracellular β2ARs upon
NE uptake by OCT3 & PMAT triggers AMPAR phosphorylation and surface delivery, thereby promoting LTP as
PKA is known to stimulate AMPAR surface insertion. We will test whether NE-induced phosphorylation
(immunoblotting; IB) and surface insertion of GluA1 (immunofluorescent microscopy; IF) and NE-dependent LTP
are abrogated by inhibitors and KO of OCT3 &PMAT. This will provide for the first time lacking but important
evidence for intracellular signaling by NE in neurons. Aim 2 is to test whether the cAMP-hydrolyzing PDE4A5
curbs upregulation of AMPARs by β2AR - cAMP - PKA signaling. We will test whether displacing PDE4A5 from
GluA1 with polypeptides elevates GluA1 phosphorylation by PKA and surface expression of GluA1 in HCs (IF)
and postsynaptic AMPARs responses (mEPSC, EPSC). Aim 3 is to determine the AMPAR - CaV1.2 interaction
sites and test the functional relevance of the AMPAR - CaV1.2 supercomplex formation. We will disrupt the
interaction by mutations and acute peptide application to determine its role in Ca2+ influx into dendritic spines
and GluA1 surface insertion by live imaging. This work will define unexplored fundamental molecular
mechanisms of how NE regulates postsynaptic functions. It will elucidate new molecular details that might be
affected in neurological diseases such as Alzheimer’s disease, which is at least in part due to dysregulation of
CaV1.2 and glutamate receptors by β2AR signaling. NE signaling is also relevant for ADHD and PTSD. The
postsynaptic assembly of specific signaling components that control PKA-mediated phosphorylation of AMPARs
and CaV1.2 and their functional interactions constitute potentially effective and specific targets for drugs that
disrupt some of these interactions while not affecting others (e.g., our peptides DSPL and Pep2 that specifically
displace the β2AR from AMPAR but not CaV1.2 and vice versa, respectively EMBO J 35,1330).
Page 1

Public health relevance
Postsynaptic Signaling by Norepinephrine and cAMP Project Narrative This project is to investigate the molecular basis of regulation of glutamatergic synaptic transmission by norepinephrine (NE), which increases our alertness and cognitive functions. Specifically, we will explore whether NE can be taken up by neurons to augment via paradigm-shifting intracellular signaling the phosphorylation of glutamate receptors (AMPARs) and thereby their postsynaptic accumulation and synaptic strength. We will characterize activation of the Ca2+ channel CaV1.2 upon stimulation of AMPAR activity by NE at postsynaptic sites, with CaV1.2 and AMPARs being major targets for NE in the brain. Aberrant functioning of NE signaling, of glutamate receptors, and of CaV1.2 are implicated in neurological and mental diseases such as Alzheimer’s disease, posttraumatic stress disorder, schizophrenia, and ADHD. Defining new molecular aspects of NE signaling will identify important new drug targets for treatment of these diseases. Page 1